An adoption study of the development of early substance use: the joint roles of genetic influences, prenatal risk, rearing environment, and pubertal maturation

Project Abstract This document has not changed from the original submission and is not required by FOA PA-21-071.

Public health relevance
Project Narrative This document has not changed from the original submission and is not required by FOA PA-21-071.